Generating Synthetic Lethality in Glioblastoma with a First-In-Class Non-Muscle Myosin II Inhibitor

PROJECT SUMMARY/ABSTRACT
We have shown that in addition to being irreplaceable for glioblastoma (GBM) invasion and mitosis,
members of the non-muscle myosin II (NMII) family of molecular motors also regulate oncogenic signaling,
mitochondrial homeostasis, and reactive oxygen formation. This suggests that targeting the two predominant
NMII isoforms in GBM (NMIIA and IIB) will synergize with signal transduction inhibitors and with therapies that
depend on reactive oxygen, including radiation. We find that MT-125, a non-toxic, CNS permeant small molecule
inhibitor of NMIIA and NMIIB prolongs median survival by ~30% as a single agent. Furthermore, when it is
combined with sunitinib, a multi-RTK inhibitor, MT-125 prolongs median survival nearly 2-fold over vehicle and
produces long term, tumor-free remissions in nearly half of mice. In addition, MT-125 sensitizes GBMs to
radiotherapy. Our central hypothesis is that by uncovering the mechanisms for these remarkable forms of
synergy between MT-125, signaling inhibitors, and radiation therapy, we can optimize the use of this highly novel
therapeutic in studies that should lay the groundwork for first-in-human clinical trials.

Public health relevance
PROJECT NARRATIVE We have identified highly synergistic combinations involving a drug that targets non-muscle myosin II combined with either a second, FDA approved inhibitor or with radiotherapy. In this application, we will examine the mechanisms underlying these forms of synergy, which will be necessary for our long-term goal of introducing non-muscle myosin II inhibitors into clinical trial.